EVALUATION OF CENTRAL VENOUS CATHETER MAINTENANCE PROTOCOLS

This protocol is designed to compare different methods for managing a patient in whom a central venous catheter has been inserted and to determine the optimal clinical lifespan of such catheters. The primary goal is to assess whether the incidence of infection differs when catheters are replaced only when clinically necessary compared with being replaced on a regular (i.e., weekly) schedule. A second goal is to examine whether sequential replacement of catheters over guide wires results in a different incidence of infection than sequential replacement at new sites. The study population consists of Clinical Center patients who require central venous catheters for clinical indications; the study randomizes the frequency and manner of catheter replacement. The outcome variables are catheter insertion site infections and catheter-related bacteremia or fungemia. The study design also allows reevaluation of the use of semiquantitative catheter cultures identify catheters sufficiently colonized to be a source of septicemia. To date, more than 190 patients have been randomized into this study.